Granular hydrogels for the controlled delivery of immunomodulatory and angiogenic extracellular vesicles to enhance bone tissue regeneration

PROJECT SUMMARY
The healing of large bone defects resulting from traumatic injuries, fracture nonunion, and tumor resection
remains a significant clinical challenge. Approximately 500,000 patients undergo bone transplants each year in
the US alone and bone diseases and their complications account for half of chronic disease among individuals
greater than 50 years old. Common surgical interventions such as autologous, allogenic, or xenogeneic bone
grafts can suffer from serious limitations (e.g., availability of grafts, donor site morbidity and pain, incompatibility,
immunogenic reactions, and infectious disease). Therefore, researchers have explored tissue engineering
approaches to develop suitable bone replacements or regeneration strategies; however, these approaches can
be complicated by a heavy, persistent immune response and inadequate vascularization throughout large
constructs in vivo. We aim to use a multifactorial approach to regenerating bone tissue by harnessing the
regenerative potential of the MSC secretome, specifically extracellular vesicles (EVs), in combination with
controlled released from porous biomaterial scaffolds. We hypothesize that controlled release of anti-
inflammatory and pro-angiogenic EVs from granular hydrogels will create a pro-healing microenvironment and
promote scaffold vascularization, improving overall bone formation by endogenous cells in critical-sized defects.
First, we will systematically identify granular hydrogel properties (e.g., porosity, stiffness, bioactive molecule
presentation) that promote MSC secretion of EVs enriched with anti-inflammatory and pro-angiogenic factors
(Aim 1). Next, we will use glycoengineering approaches to produce modified EVs that can be conjugated to our
granular scaffolds via strain-promoted alkyne-azide cycloaddition (SPAAC) chemistries before encapsulating
cells within EV-laden scaffolds to investigate the influence anti-inflammatory and pro-angiogenic EVs on
macrophage polarization and vascularization, respectively, in vitro (Aim 2). We will then fabricate granular
hydrogels using heterogeneous populations of microgels to vary in vivo degradation and enable temporal control
over EV release profiles. We will conduct a short-term (7 days) rat subcutaneous implant study to test the
capacity of EV-laden granular scaffolds to modulate early inflammation and vessel invasion, providing iterative
feedback on scaffold design. Finally, we will interrogate the ability of these complex granular scaffolds to
modulate inflammation, vascularization, and osteogenesis to promote bone regeneration by endogenous cells
in a rat critical-sized calvarial defect model (Aim 3). This proposal will utilize sophisticated experimental
techniques to explore the complexities of cell-cell, cell-matrix, and cell-EV interactions. The contributions of this
proposal would significantly impact the wide array of regenerative medicine strategies focused on granular
hydrogels, extracellular vesicle therapeutics, and bone tissue engineering.

Public health relevance
PROJECT NARRATIVE The healing of large bone defects, greater than the intrinsic capacity of self-regeneration, remains a significant clinical challenge with approximately 500,000 patients undergoing bone transplants each year in the US alone. Natural fracture healing involves a coordinated series of biological events, including inflammation, vascularization, and osteogenesis, precisely orchestrated in time and space, to repair and regenerate bone tissue. The proposed research aims to develop an innovative biomaterial approach in which granular hydrogels are used to manipulate the regenerative secretome, specifically extracellular vesicles (EVs), of bone marrow- derived mesenchymal stem/stromal cells and then subsequently engineered to serve as delivery vehicles for the local presentation and sustained release of EVs in vivo to promote bone tissue regeneration in critical-sized bone defects.